Probing How Living Bacterial Membranes Control Small Molecule Uptake

Project Summary/Abstract
Our research program aims to directly probe how the complexity of living bacterial membranes impacts the
adsorption, transport, and domain association of small molecules, including antibiotics. To address these
points, we will leverage nonlinear spectroscopy and microscopy techniques, speciﬁcally second harmonic
generation, to map the dynamic behavior. A key to our methodology is the ability to conduct the proposed
experiments on living cells instead of model systems. For the next 5 years, our program goals are to
(1) extract the key factors that inﬂuence the adsorption and membrane organization of small molecule
membrane probes, (2) quantitatively assess the adsorption of tetracycline antibiotics and manipulate their
movement within and through the membranes of different species of bacteria, and (3) examine the spatial
dependence of small molecule-membrane interactions on individual bacteria as well as within bioﬁlms.
Together these studies will elucidate the role of how parameters including curvature, membrane domains,
and the cell wall mediate small molecule uptake. We envision that this insight will provide new directions
in the continued pursuit of improved antibiotics.

Public health relevance
Project Narrative The success of an antibiotic is dependent on it's ability to bind to and move through the cell membrane of its bacterial target. Our research program applies new technologies that allow us to “watch” native antibiotics interact with living bacterial cells and study the factors that inﬂuence their activity. This new insight can provide crucial information for designing drugs to combat antibiotic resistance.